Collaborative Project

Project Summary/Abstract (Collaborative Project)
In this project a set of recently developed experimental and computational tools for antigen
discovery will be utilized to identify antigens of microbial and self origin in IgG4-related disease
and in systemic sclerosis. The focus will be to identify T cell antigens from the microbiome and
from the host extracellular matrix. Detailed metagenomic analyses of the microbiome will be
performed to identify microbial antigens of relevance. In addition, peptide antigens from the host
extracellular matrix will be screened for presentation by MHCII and evidence of T cell
immunogenicity. Finally, attempts will be made to identify shared T cell epitopes derived from
host and microbial antigens that are targeted by B cells.